Obesity: From Genes to Man

DESCRIPTION (provided by applicant): Obesity/overweight is rampant in the U.S. and has been acknowledged as the second leading cause of death. Obesity has been linked to diabetes, hypertension, cardiovascular disease, and cancer. Efforts to understand and manage this complex disease have met with modest success such that obesity continues to grow in prevalence at an alarming rate in both adults and children. It is likely that research which transcends traditional boundaries of research and focuses on cross-disciplinary approaches to research questions may provide the answers needed to conquer this grave threat to the health. This application is a request for renewal funding for the Pennington Biomedical Research Center (Louisiana State University System) training program Obesity: From Genes to Man. This program was funded originally in 2003, and renewed successfully in 2007. One of the aims of this grant is to train postdoctoral fellows in the complex interactions between genetic, molecular, physiological, and behavioral aspects of obesity. The objective of this program is to train Ph.D. and M.D. postdoctoral fellows to become productive research scientists capable of establishing scientific careers in academia, academic medicine, governmental agencies, and in the private sector. These junior scientists will further the efforts of the NIH to understand the complex interactions between genetic, molecular, physiological, and behavioral aspects of obesity. Many molecular biologists/geneticists are interested in obesity-related research, but lack the physiological/metabolic/behavioral expertise to maximize their research discoveries. Conversely, physiological /metabolic/behavioral studies need molecular and genetic approaches for a fuller understanding. We aim to bridge the divide between the molecular/genetic approaches and the physiological/behavioral studies of the functions of specific genes by providing training in these areas. Each postdoctoral fellow will be encouraged to develop these transdisciplinary research efforts to understand multiple aspects of obesity and obesity-related disease. The program will take advantage of the cutting-edge technologies and the wide range of research efforts related to obesity available at Pennington Biomedical. This broad-based, training program will enable trainees to acquire transdisciplinary research skills and write competitive grant proposals addressing important questions which will move our science forward. The faculty of Pennington Biomedical are committed to postdoctoral research training and see this as inseparable from their goal of excellence in research. This application is requesting five additional years of funding for six (6) trainee positions per year. We will recruit M.D.s and Ph.D.s from the basic, clinical, and population science disciplines including biology, physiology, kinesiology, neuroscience, public health, and psychology. The majority of trainees will enter into the program with no prior postdoctoral training. However, for the first year of funding, we have requested three slots for individuals with prior training in order to accommodate those fellows currently in the program who remain eligible to continue. Trainees will be supported for two to three years.

Public health relevance
PUBLIC HEALTH RELEVANCE: Obesity/overweight is the second leading cause of death, and has been linked to diabetes, high blood pressure, and cancer. Research which focuses on combining approaches from basic, clinical, and population science may find the answers needed to conquer this public health threat. The objective of this grant is to train junior-level scientists in understanding the complex relationships between genetic, molecular, physiological, behavioral, and population aspects of obesity.